Co-engineering Hebbian and Homeostatic Plasticity Mechanisms to Induce Targeted Functional Neural Connectivity Changes

Project Summary:
Our memories and behaviors are encoded by the plastic changes in connectivity between the trillions of synapses
connecting the neurons in our brains. Neurological disorders such as schizophrenia, epilepsy, and stroke often
result in aberrant neural connectivity that causes debilitating deficits in cognition and behavior. One approach to
treating these disorders is to harness the brain’s natural plasticity mechanisms to restore lost function following
injury through neural stimulation. These plastic connectivity changes occur through two main identified
mechanisms: Hebbian and homeostatic plasticity. In accordance with Hebbian plasticity mechanisms,
connections are strengthened or weakened when activity between neurons is correlated or uncorrelated,
respectively. Stimulation-based approaches attempt to utilize this mechanism for inducing plastic changes with
limited efficacy to strengthen connectivity (long-term potentiation, LTP), while neglecting the effects of
homeostatic plasticity mechanisms. Homeostatic plasticity mechanisms alter connectivity to maintain consistent
neuronal activity levels by modifying synaptic strengths, levels of inhibition, and the threshold for LTP induction
based on previous activity levels. Here, I hypothesize that homeostatic plasticity plays a significant role in
determining Hebbian-informed stimulation-induced plasticity outcomes and that both mechanisms of plasticity
can be engineered to improve these outcomes towards strengthening corticocortical connectivity. In aim 1, I
assess the impact of reducing neuronal activity on Hebbian-informed stimulation-induced functional connectivity
changes in healthy and diseased states. In the diseased state, I will measure the impact of this strategy on
promoting functional recovery following targeted cortical lesioning. In aim 2, I explore the suppression of
homeostatic plasticity mechanisms that oppose Hebbian-informed stimulation-induced functional connectivity
changes. The outlined research strategy will allow me to build experimental and professional skills that will propel
my career as I transition into a postdoctoral position. By incorporating homeostatic plasticity mechanisms in the
design of Hebbian-based stimulation protocols for targeted neural connectivity change, the findings of the
proposed study can transform the efficacy of future stimulation-based therapies for neurological disorders.

Public health relevance
Project Narrative Relevance: The brain possesses the remarkable plastic ability to change its connectivity, which is often disrupted following injury or neurological disorder, making these plastic mechanisms a target of brain stimulation-based therapies. The goal of this study is to integrate principles from multiple plasticity mechanisms to enhance our ability to induce functional connectivity changes through neural stimulation and promote functional recovery following injury. The results of this study will then be used to inform the development of stimulation-based therapies for neurological disorders, for example to restore lost functions or behaviors following injury.